MITOCHONDRIA IN CHRONIC FATIGUE SYNDROME PATHOPHYSIOLOGY

The purpose of this study is to determine if mitochondrial bioenergetic function is impaired in the cells of Chronic Fatigue Syndrome (CFS) patients compared to normal, healthy individuals.